PROJECT 2

PROJECT 2 – CHEMICAL BIOLOGY OF DNA DEAMINASES IN BREAST CANCER
ABSTRACT
APOBEC enzymes are single-stranded DNA cytosine-to-uracil deaminases that normally protect cells from
viral infections. However, APOBEC3B (A3B) has been implicated in mutations in breast cancer that drive tumor
evolution and contribute to the development of drug resistance and, ultimately, therapy failure. A3B is
overexpressed in over half of all estrogen receptor (ER)-positive breast tumors, the most common type, and is
associated with poor overall survival. Our Program has shown that inhibition of A3B-mediated tumor evolution
improves therapy outcomes in a mouse model of ER-positive breast cancer. Our Program’s unifying
hypothesis is that A3B inhibition will prevent a large proportion of new mutations in ER-positive breast cancer,
thereby improving the durability of current treatments and resulting in better overall outcomes. To address this
hypothesis our Program is focused on understanding the biology of A3B in breast cancer cells (Project 1);
developing innovative nucleic acid probes to molecularly characterize how A3B engages DNA substrates and
small molecules to inhibit A3B-catalyzed breast cancer mutations (Project 2); and generating A3B x-ray
structures with nucleic acids, small molecules, and protein ligands to understand the structural basis of A3B-
mediated DNA mutagenesis and its inhibition to enable development of therapeutic compounds (Project 3).
These activities will be supported by Service Cores for administration (Core A), animal models of A3B-driven
breast cancer (Core B), computational chemistry and biophysics (Core C), and protein and antibody production
(Core D). Project 2 – Chemical Biology of DNA Deaminases in Breast Cancer will lead the chemical probe
discovery efforts by 1) synthesizing complex nucleic acid ligands for A3B to characterize how A3B
discriminates 2¢-deoxycytidine from other nucleotides and to understand which nucleic acid features enable
A3B to deaminate discrete DNA sequences, including its overall preference for binding DNA versus RNA; and
2) using complimentary technologies and approaches to develop first-in-class small molecule inhibitors of A3B
that will be used in mechanistic cellular assays of A3B-driven breast cancer mutation (Project 1), structural
biology studies to annotate A3B-ligand binding (Project 3), and therapeutic utility experiments in animal models
of breast cancer (Core B). Our studies will be enabled by critical collaborations involving computational ligand
design (Core C) and access to high-quality biological reagents for assays (Core D), and our advances will
position our novel compounds for future therapeutic development. Potent, selective chemical probes of A3B
with in vivo activity, as well as novel assays, are the major anticipated deliverables of Project 2. As such,
Project 2 will be the center of chemical innovation for the Program, accelerating all Projects and contributing to
the achievement of our overall research objectives.

Public health relevance
PROJECT 2 – CHEMICAL BIOLOGY OF DNA DEAMINASES IN BREAST CANCER NARRATIVE APOBEC3B (A3B) is a DNA-mutating enzyme frequently activated in breast tumors, which contributes to breast tumor evolution including mutations that cause drug resistance. The long-term goal of this Program is to therapeutically inhibit A3B and thereby help to suppress detrimental outcomes such as drug resistance and metastasis. Project 2 – Chemical Biology of DNA Deaminases in Breast Cancer will contribute to this overarching goal by developing novel nucleic acid and small molecule A3B modulators that will serve as valuable mechanistic probes of A3B function and provide lead compounds for future drug development.